Self-Perception and Social Rewards in Atypical Anorexia Nervosa

PROJECT SUMMARY
Eating disorders (ED) are serious mental illnesses with few evidence-based treatments and little mechanistic
understanding of the neural circuit impairments that underlie both illness and recovery. This project contributes
to developing a more dimensional understanding of EDs, by comparing the neural circuits involved in both self-
perception and social reward in a previously unstudied clinical cohort, atypical anorexia nervosa (AAN) to a
psychiatrically-healthy cohort that has lost similar amounts of body weight (WLC). Typical anorexia nervosa (AN),
for the purpose of research and clinical care, is defined by a malnourished body state (BMI < 18.5) with persistent
behaviors that interfere with weight restoration, and often includes preoccupations with body image. Atypical
anorexia nervosa (AAN) was defined in DSM-5 as meeting all criteria for AN without being underweight; these
patients have typically experienced substantial weight loss due to severe restrictive eating behaviors as well as
disruptions of their psychosocial functioning due to the severity of their ED cognitions. Clinically, AAN is
associated with similar to higher levels of psychological distress and distortions about both eating and body-
image as typical AN. This exploratory pilot project will evaluate whether similar neurobehavioral problems in self-
perception and social reward are observed in the brain in AAN, extending an existing R01 that is currently
examining these circuits in both AN and bulimia nervosa (BN). In addition, the psychiatrically-healthy weight loss
cohort (WLC) will have experienced significant weight loss (10-20% of highest body weight) but will not endorse
pathological ED cognitive preoccupations; this cohort, in comparison to AAN, allows separation of the impact of
weight loss on brain function from the neuropsychological processes that mediate body preoccupations. In sum,
this exploratory pilot study evaluates neurobiological circuitry in an understudied diagnosis, AAN, and provides
the necessary data to fill current gaps in our knowledge about the effects of weight and ED cognitions on neural
function as well as clinical symptoms in EDs. These data are a step towards a more mechanistic understanding
of the pathophysiology in EDs.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Atypical anorexia nervosa is a serious and understudied eating disorder defined by substantial weight loss, severe restrictive eating behaviors, cognitive disturbances related to eating and body image, but without the low body mass index observed in typical anorexia nervosa. This exploratory project will determine if social rewards and self-perception are altered in atypical anorexia nervosa (akin to prior work in typical AN) in comparison to healthy women that have lost weight without developing eating disorder psychopathology, such as overly restrictive eating or distortions about body image. Further, these novel cohorts allow weight loss to be separated from the cognitive distortions common in eating disorders, a critical step in developing a more mechanistic and dimensional understanding of eating disorders.